Environmental Influences on Child Health Outcomes in the Northern Plains Safe Passage Study Cohort

Project Summary/Abstract
This administrative supplement is to allow for the acquisition of a mobile research lab to assist
with in-person ECHO recruitment and data collection, particularly in rural areas and with hard-to-
reach populations. In the fall 2020, in response to the challenges of COVID-19, we removed our
ECHO catchment requirements around Sioux Falls and Rapid City, SD (location of research
offices), and expanded recruitment throughout the region to better capture rural participants. This
approach has been tremendously successful with increasing engagement of rural/frontier
participants, with approximately 50% of our ECHO participants now living in rural areas. The
mobile research lab will be used to enroll and collect data from those participants with limited
access to on-line data collection tools. In addition, the mobile research lab would allow us to
collect study elements difficult to collect in a remote environment, including certain biospecimens,
cognitive assessments, anthropometrics, blood pressure, and others.

Public health relevance
Project Narrative This administrative supplement is to allow for the acquisition of a mobile research lab to assist with in-person ECHO recruitment and data collection, particularly in rural areas and with hard-to- reach populations. The mobile research lab will be used to enroll and collect data from those participants with limited access to on-line data collection tools. In addition, the mobile research lab would allow us to collect study elements difficult to collect in a remote environment, including certain biospecimens, cognitive assessments, anthropometrics, blood pressure, and others.